Duke-N.C. Central Alcohol Research & Education (D-CARE)

Abstract
Representation of minority groups in biomedical research, including research on alcohol effects and alcohol
use disorders, is low; and individuals who identify as members of underrepresented minority groups (URMs)
pursue such careers at far lower rates than expected considering the demographics of the U.S. This project will
focus on cultivating the interest of undergraduate students in alcohol related research to increase the pool of
diverse applicants pursuing alcohol-related research careers. We have established a partnership between
Duke University (a private, R1 university) and North Carolina Central University (NCCU; a public HBCU). Our
program, entitled Duke-N.C. Central Alcohol Research & Education (D-CARE) will provide educational,
research training, and intensive mentoring for undergraduates from both institutions. D-CARE will: 1) Focus
entirely on undergraduates; 2) Pair laboratories and academic courses from Duke and NCCU to provide
innovative alcohol-related academic and research opportunities to URM students from both institutions; and 3)
Provide a wide range of professional development opportunities and track the progress of participants as they
complete their undergraduate training and move forward into graduate or professional education. A primary
goal of the program will be for students from each institution to study and train with students from the other,
thereby leveraging the distinct strengths of each university. Aim 1 will promote in-depth understanding of the
biomedical, public health, social and cultural impacts of alcohol through didactic training, and engagement with
the Research Triangle alcohol research community by providing a semester-long course focused on alcohol
and its various biological, clinical, and social impacts. This Aim will also establish a rich professional network
through which D-CARE participants will acquire specific skills and guidance toward careers related to alcohol
research. Aim 2 will provide an immersive summer alcohol research experience in Duke and NCCU
laboratories that includes personalized research mentoring, and both group and individualized professional
development education. Aim 3 will provide continuing professional development and mentoring opportunities
for participants, and an empirical evaluation component to document participants' progress toward career
goals and follow their progress beyond their undergraduate experience. The program will continue to support
participants by providing monthly meetings with program mentors throughout the following academic year. In
addition, meetings and resources will be provided to support students' specific research endeavors including
advice on poster construction, presentation planning, graduate school/employment applications, and evolving
career development considerations. The program will also provide specific preparatory advice and support for
participants attending scientific conferences in the academic year following the summer research experience.

Public health relevance
Project Narrative The field of alcohol studies lacks racial and ethnic diversity, and few systematic efforts exist to engage undergraduate students in alcohol-related research or coursework. This project will engage undergraduates from underrepresented minority groups in a coordinated program including didactic coursework, intensively mentored research experiences, and professional development activities related to alcohol studies and careers in alcohol-related fields. The goal is to broaden the diversity of the next generation of researchers in the field of alcohol studies.